The Peripheral Representation of Odor Space

Summary (Project 1: The peripheral representation of odor space)
Progress towards an understanding of olfactory coding has been hampered by long-standing hurdles created by
the nature of the stimulus and the complexity of the underlying sensory biology. At the same time, a description
of olfactory coding in mammals would provide a unique window into how multidimensional stimuli are
represented by the mammalian brain. Olfactory systems use large families of odorant receptors to detect a vast
number of chemical stimuli. An important challenge that must be overcome to better understand olfaction is to
establish a comprehensive description of what features of olfactory stimuli are represented by the system. Doing
so requires that we overcome previously insurmountable technical challenges in identifying the stimulus
specificity of a large number of receptors to a large number of odorants, and that we generate a theoretical
framework for quantifying and exploring the multidimensional “space” of odors and receptors. Here, we propose
an interdisciplinary effort to comprehensively characterize the odorant response properties of a large number of
odorant receptors in vivo, and to use this information to explicitly and rigorously test novel models of odor coding.
This project exploits the one-to-one correspondence between odorant receptors and glomeruli in the olfactory
bulb of mice. Aim 1 will characterize the sensitivities of a large number of receptors (glomeruli) in awake, intact
animals using functional imaging. Aim 2 will map these glomerular responses to specific receptors using
emerging spatial transcriptomics methods. Aim 3 will use a powerful genomics-based assay to identify the
highest affinity receptors for a large set of individual odors. Aim 4 will test a novel theoretical framework for
understanding how odor features are represented. This large-scale in vivo multidisciplinary approach will provide
long-sought data and analytical tools to rigorously explore potential models of odor coding.